Molecular Biophysics Training Program

The Molecular Biophysics Training Program (MBTP) at the Weill Cornell Graduate School (WCGS) is built on a decades-long history of biophysics research and training at the two research centers comprising WCGS - Weill Cornell Medicine (WCM) and the Memorial Sloan-Kettering Cancer Center (MSKCC) located across the street from each other. MBTP will bring together biophysics trainees from two WCGS graduate programs: the Biochemistry & Structural Biology (BSB) program, part of the umbrella Biochemistry, Cell and Molecular Biology (BCMB) program and the Physiology, Biophysics and Systems Biology (PBSB) program. Union of the biophysics trainees in these two programs is a natural fit given that biophysics is inherently multidisciplinary – bringing together biology, chemistry, physics, computational biology, and mathematics. MBTP will provide: 1) outstanding learning and mentoring for predoctoral trainees in molecular biophysics; 2) world-class research opportunities; 3) an interactive and interdisciplinary cohort of students and faculty to foster scientific exchange and collaboration; 4) strong foundation in performing rigorous and reproducible scientific research and 5) knowledge of and exposure to various career paths for successful transition into the biomedical research workforce. The formation of the MBTP program is the latest in a nearly three-decade maturation of synergistic connections between WCM and MSKCC.

Public health relevance
The Molecular Biophysics Training Program is designed to yield a cohort of new PhDs with the skills to apply quantitative approaches rooted in physics to biomedical problems. The program will draw students from two complementary graduate programs shared between Weill Cornell Medicine and Sloan Kettering Institute. It will generate scientifically rigorous, thematically organized, cohesive and interdisciplinary educational and training environments to prepare students for various careers in academic and non-academic fields following timely completion of their doctoral degrees.